Discovery of small molecule promoters of cardiomyocyte proliferation to restore cardiac performance in disease

TITLE: Discovery of small molecule promoters of cardiomyocyte proliferation to restore cardiac
performance in disease
PROJECT SUMMARY
Cardiovascular disease is the leading cause of mortality in developed and developing nations. Existing CVD
pharmacotherapy options do not treat any foundational problems in the myocardium and its constituent
cardiomyocytes; rather, unloading the heart and reducing vascular risk factors are the primary therapeutic
strategies. Future strategies should move beyond prevention and treatment to restoration, regeneration, and
replacement of functional cardiac tissue. Two fundamental challenges face the several mechanisms of
potential cardiomyocyte renewal (proliferation of endogenous cardiomyocytes, resident progenitor cells, or
extracardiac progenitor cells including bone-marrow derived or pluripotent cells): can a sufficient number of
new cardiomyocytes be generated to meaningfully improve cardiac function in various diseases? And since
most tissues in adult mammals remain post-mitotic to minimize the risk of cellular transformation into an
uncontrolled proliferating neoplastic state, can cardiomyocyte-specific proliferation mechanisms be discovered
and manipulated? It is unclear that the reported mechanisms of cardiomyocyte proliferation meet both of these
challenges. We have recently developed a novel platform to conduct high throughput screening (HTS) on
functional human cardiomyocytes matured from iPS cells. Our innovation is a hypothesis-free, phenotypic
screening cascade designed to discover previously unknown, cardiomyocyte selective promoters of
cardiomyocyte proliferation. Our hypothesis is this approach will ultimately generation drug-like starting points
for future disease-modifying cardiovascular therapeutics. The primary HTS assay has been fully optimized in a
384-well format, and as a demonstration of assay readiness, 12,000 compounds have been screened (Z’-
factor of 0.4). Multiple hits from pilot screens were identified and were confirmed and validated in concentration
response experiments. A battery of downstream assays has been developed to establish a critical path-testing
funnel. Several compounds identified from the pilot screen specifically promoted cardiomyocyte proliferation
versus fibroblast proliferation, and furthermore promoted ex vivo proliferation in both neonatal and adult
cardiomyocytes isolated from rats. This proposal builds on data from the applicants, an established team from
SBP (Drs. Larson and Colas) with basic biology and drug discovery expertise in the field and access to all
necessary technologies. The overall goal of this proposal is to generate chemical biology research tools and
the starting points for new drugs. As the critical path assays are all in place, we anticipate we can rapidly
obtain such probe molecules and start to explore their activity. Our future plans beyond this grant are to
ultimately determine their suitability for hit-to-lead activities, begin in vivo evaluation of lead compounds in
animal models and eventually patients, and determine their cellular mechanism of action. The product of the
work proposed in this application will serve as preliminary data for both hit-to-lead (HTL) grant submissions
and parent R01 grant submissions to pursue basic biology understanding of their mechanisms.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease is the leading disease burden globally, and decades of major research investments have not substantially improved people’s overall survival of acute or chronic cardiac deficits from the survival benefits provided by recent additions of surgical interventions to older medications treating heart rate, blood pressure, or elevated lipids. A fundamental problem in most cardiac diseases is that the number of functional cardiomyocytes is insufficient for the heart to pump enough to oxygenate the body’s organs, so discovering or developing agents that will stimulate endogenous cardiomyocyte proliferation to increase the number of functional cardiomyocytes to this level is important. The goals of this application are: (1) to identify prototype drugs (i.e. compounds / probes) that can stimulate endogenous cardiomyocyte proliferation through use of a high throughput screen of a large chemical library against human cardiomyocytes matured from pluripotent stem cells; (2) to explore the activity of these chemical probes in cellular systems to provide insight into the biology of this important process; and (3) to advance our long-term goal of developing a disease modifying treatment for cardiovascular diseases.